Project 2: DSBR: Mechanisms of DNA double strand break repair and pathway selection

SUMMARY - Project 2: DSBR: Mechanisms of DNA double strand break repair and pathway selection
Understanding how cells detect and repair DNA double strand breaks (DSBs) is critical to improving patient
responses to radiation therapy and many forms of chemotherapy. The major pathway for repair of DSBs in
normal cells is non-homologous end joining (NHEJ), which is active throughout interphase but error prone.
However, in S and G2 phases, the more accurate homology directed repair (HDR) pathway is also active.
Moreover, cancer cells sometimes use highly error-prone, mutagenic alternative-end joining (Alt-EJ) pathways
for DSB repair. While we know a significant amount about the proteins involved in each pathway, there are wide
knowledge gaps in understanding how these pathways intersect and how they are regulated in normal and
cancer cells. Project 2 brings together leading investigators with expertise in NHEJ, HDR and Alt-EJ to determine
how DNA end resection directs DSB repair pathway choice. In Aim 1 we will determine how NHEJ proteins
tether broken DSB ends in synaptic complexes prior to processing to remove damaged end groups, and how
DNA ligase IV uniquely catalyzes rejoining of DSB ends. We will also determine how the nuclease Artemis and
the end-processing enzyme PNKP interact with synaptic complexes, providing the first comprehensive view of
how NHEJ complexes function at DSBs. In Aim 2, we will explore how Artemis interacts with the MRN complex
to regulate the initial stages of resection, how the short- and long-range resection machineries are coupled and
how the tumor suppressor BRCA1-BARD1 complex stimulates long range resection by DNA2/BLM. In Aim 3 we
will determine how XRCC1/DNA ligase III interacts with MRN and DNA polymerase  to link DNA resection,
gap-filling DNA synthesis and ligation during Alt-EJ and how DNA polymerase  interacts with the key HDR
protein, RAD51. Our studies will yield unprecedented molecular level insights into fundamentally important DNA
repair pathways, and will also paint a comprehensive picture of how DSB repair pathways act together as an
integrated network to repair radiation and chemotherapy-induced DSBs in cancer cells and non-malignant cells.
The information generated by Project 2 will pave the way for novel approaches to better target tumors in the
clinic. Indeed, small molecule inhibitors of NHEJ protein DNA-PKcs are in clinical trials and inhibitors of Artemis,
PNKP, MRE11 and DNA ligases are being evaluated in pre-clinical cancer models, Moreover, novel Pol 
inhibitors with the potential to selectively target cancer cells that are dependent upon Alt-EJ will be identified in
Project 2 by our structure-based approaches. EMB core expertise in protein expression and cutting-edge
biophysical approaches of the SCB core are critical for the success of our project, which is fully synergistic with
Project 4 on replication fork preservation, Project 3 on the role of PARP1 and PARylation in DSB repair, and
Project 1 on the cellular responses induced by DSB-inducing chemotherapeutics. We will share and exchange
ideas, results, and reagents with all the SBDR investigators, contributing to a scientific environment conducive
for advancing mechanism- and structure-based cancer therapies and for the training of students and fellows.

Public health relevance
NARRATIVE - Project 2: DSBR: Mechanisms of DNA double strand break repair and pathway selection Most cancer patients are treated with DNA double strand break inducing radiation and chemotherapy. Project 2 aims to understand how normal and cancer cells detect and repair DNA double strand breaks by integration of three major cellular pathways, non-homologous end joining, homology-directed repair and alternative end joining, leading to novel insights into mechanism and uncovering new approaches for therapeutic targeting.